Promoting Effective Clinical Communication about Sexual Health after Gynecologic Cancer: A Randomized Controlled Trial of a Patient-Focused Intervention

PROJECT SUMMARY
Sexual problems are common, distressing and persistent for patients with gynecologic cancer (GC). Yet most
patients with GC who experience sexual concerns do not raise them with their clinicians, often due to a lack of
preparation for how to do so effectively. Negative beliefs, such as low self-efficacy for initiating discussions of
sexual health or expectations for the discussion, further limit patients’ active engagement in these discussions.
A patient-focused theory-guided intervention, Starting the Conversation (STC), could be ideally suited to address
these challenges and empower patients to drive clinical discussions to meet their needs. STC was developed
for use with breast cancer (BC) patients and found effective in that population. Compared to BC patients,
however, GC patients undergo different treatments, experience unique sexual health concerns, and have distinct
needs for a sexual health communication intervention. Therefore, we modified STC to suit the needs of women
with GC and conducted a pilot trial of the new intervention, called STC – Gynecologic Cancer (STC-GC), finding
strong support for its feasibility and acceptability. Before this intervention can be disseminated, its efficacy in the
target population must be evaluated. The primary objective of the proposed study is thus to evaluate the efficacy
of the STC-GC intervention among patients treated for GC reporting sexual concerns. Female patients with any
stage GC (N=200) will be randomized to receive either the STC-GC intervention [video, workbook, and resource
guide] or to a control [usual care plus resource guide]. In Aim 1, we will evaluate the efficacy of STC-GC in
facilitating patient clinical communication about sexual health (primary), assessed using rigorous dialogue
analysis of patients’ clinical communication about sexual health, and in improving patients’ sexual and
psychological health outcomes at post-intervention and 2- and 6-month follow-up (secondary). In Aim 2, we will
examine whether intervention-related increases in patients’ self-efficacy and outcome expectancies for sexual
health communication mediate effects of STC-GC on patients’ communication (Aim 2a) and whether enhanced
sexual health communication mediates effects of STC-GC on patients’ sexual and psychological health
outcomes (Aim 2b). In Aim 3, we will conduct in-depth qualitative interviews with a purposive sample of patients
in STC-GC and with clinicians of GC patients to provide information from multiple perspectives to contextualize
and interpret the quantitative findings of the trial. As the first efficacy trial of a sexual health communication
intervention for women with GC, findings from this study will be instrumental in advancing efforts to integrate
sexual health into routine cancer care. Further, the proposed study has a number of unique features, including
a qualitative investigation of multiple perspectives, novel application of dialogue analysis, analysis of multiple
intervention mediators, and a medically inclusive patient population, which heighten study impact and innovation.
Data from this study will serve as the platform for a future dissemination trial of STC-GC in multiple settings.

Public health relevance
PROJECT NARRATIVE Many patients with gynecologic cancer experience treatment-related sexual health concerns but do not raise these concerns with their clinicians due to a lack of preparation for how to do so effectively. The objectives of the proposed study are to evaluate the efficacy of a patient-focused intervention designed to promote clinical communication about sexual health for patients with gynecologic cancer (Starting the Conversation – Gynecologic Cancer; STC-GC), to test intervention mediators, and to obtain qualitative data from patients and clinicians to contextualize and interpret quantitative findings of the trial. This study has public health relevance because enhancing gynecologic cancer patients’ communication about sexual health would directly impact clinical care and could improve patients’ sexual and psychological health.